Administrative Core

ADMINISTRATIVE CORE: PROJECT SUMMARY/ABSTRACT
The Stanford Diabetes Research Center (SDRC) seeks support for its efforts to discover, apply, and
translate scientific knowledge about diabetes, obesity, and metabolism to improve public health by reducing
the burden of disease from diabetes. The Administrative Core coordinates, allocates and oversees resources
and provides oversight to ensure the smooth operation of the SDRC, including the Research Cores, Pilot &
Feasibility Award Program, Regional Pilot & Feasibility Award Program, and Enrichment Program.
Coordination of these activities is facilitated through the maintenance and curation of a Center website. The
Administrative Core includes the Director, the Associate Director, an Administrative Assistant, a Program
Manager, and a Web Administrator. The Director assumes responsibility for the scientific and training
directions of the SDRC. The Associate Director assists the Director as needed in the operation of the SDRC,
and assumes full responsibility for the SDRC when the Director is not present. The Administrative Core aims
include fostering membership in the SDRC to stimulate and ensure the growth and maintenance of the vibrant
research investigator base, guiding the career development of junior investigators in diabetes related research,
enhancing the environment of training, education and knowledge about opportunities in diabetes research at
Stanford, and providing a framework for continuous growth and evolution of resources at Stanford, including
links to local, national and international constituencies, that enhance diabetes related research.
The SDRC Enrichment Program leverages strengths of Stanford University to enhance diabetes research
and training. The goals of this program are: 1) To advance diabetes research by serving as the organizing
nexus of enrichment activities to foster interdisciplinary education, idea sharing and collaboration, across
Stanford and in partnership with regional institutions like the University of California (UC) Davis, and UC
Berkeley. 2) To attract, support and train future diabetes research leaders who will advance diabetes-related
knowledge and improve patient care; 3) To facilitate and support the numerous local and national community
outreach programs that Stanford has established to improve patient awareness, empowerment and advocacy.
The SDRC enhances the environment for diabetes research and training at Stanford through multiple efforts
including the establishment of diabetes-research affinity groups to facilitate knowledge-sharing and
collaboration, monthly diabetes research-in-progress seminar series, multiple regional lecture series for invited
speakers, early-stage investigators and trainees, an annual Diabetes Research Day Symposium that
showcases new and evolving ideas, career development through mentoring and SDRC-specific course
offerings, and the spectrum of training grant opportunities including NIH T32 training programs and numerous
patient-oriented events that occur on campus as well as within the community. Together these contribute to
create a vibrant, energized research base with national and international impacts on diabetes research.